Use of Chemically Modified RNA to Enhance Bone Healing

PROJECT SUMMARY/ABSTRACT
This proposal addresses the problem of bone healing in large segmental osseous defects that occur as a result
of injury, tumor resection or the correction of congenital deformities. They present important clinical problems
because they heal poorly and there are no clinically expedient ways to regenerate the lost bone. Much interest
was aroused by the cloning of bone morphogenetic proteins (BMPs), which have potent osteogenic properties
in animal models. Recombinant BMP-2 and BMP-7 advanced to clinical use, but they have improved the field
only incrementally. Their disappointing clinical performance is thought to reflect delivery problems. The
proteins are mixed with a collagen scaffold and surgically implanted into a bone defect in the operating room.
Most of the BMP leaves the defect within hours. To address this, massively supraphysiological amounts of the
BMP are implanted, leading to major side-effects and greatly increasing the cost. Attempts to improve the
delivery of the BMPs have focused on the development of scaffolds that incorporate BMPs and release them
slowly after implantation, and gene therapy, which enables cells within and around the osseous defect to
synthesize their own BMP endogenously. Recent data from the latter approach demonstrate that, when the
BMP is synthesized endogenously, expression of the BMP needs to be neither prolonged nor high for effective
bone healing. This raises the possibility of delivery mRNA rather than DNA to enable local, endogenous
synthesis of the BMP. While theoretically satisfying, this approach is restricted because mRNA is unstable,
toxic to cells and inflammatory. This project will explore the use of chemically modified RNA (cmRNA) that
lacks these disadvantages. Among the chemical modifications are the inclusion of iodo-substituted pyrimidines
uracil and cytosine; the introduction of specific 5’-untranslated regions (UTRs); and the inclusion of an
extended polyA tail. Chemically modified RNA technology was invented and pioneered at the Technical
University of Munich (TUM), which has produced a cmRNA encoding BMP-2. Pilot studies in the PI’s
laboratory in collaboration with TUM have confirmed that BMP-2-cmRNA heals critical size defects in the rat
femur with impressive speed and reliability. Funds are thus requested by this collaboration to develop the work
further with the goal of eventual human trials. This proposal seeks to establish the central premise that healing
of critical size defects is effective when BMP-2 is expressed locally and transiently from cmRNA molecules. A
rat, femoral critical sized defect will be used in both male and female animals. Specific Aim 1 will determine the
location, duration and level of cmRNA expression. Specific Aim 2 will study the biology of healing, particularly
with regard to identifying the cells that express and respond to BMP-2. Because large animal studies are a
necessary prelude to contemplating human trials, Specific Aim 3 will use a sheep drill hole model to establish
whether BMP-2-cmRNA is osteogenic in sheep.

Public health relevance
PROJECT NARRATIVE When large pieces of bone are lost through injury or some other cause, the body is unable to regenerate them. This project will explore a new way of healing such large bone defects. It is based upon the use of chemically modified RNA that directs cells around the damaged bone to make a protein called bone morphogenetic protein-2 which promotes bone formation. This technology will be tested in rats and sheep.